Glucocorticoid Receptor Mechanisms of Traumatic Stress Pathology

Incidence of post-traumatic stress disorder is a major problem for the VA, affecting roughly 13% of individuals
serving in OIF or OEF. Women appear to be more susceptible to development of PTSD than men, often
occurring in the context of sexual assault (which can occur during military service). Frontline treatment options
can improve symptoms but do not currently offer a cure. To develop further strategies to this end, it is critical
to understand the foundations of the disease process as it develops. The proposal is designed to test the
hypothesis that hormonal responsiveness to stress and trauma are critical for driving susceptibility to
development of behavior pathologies relevant to PTSD. In humans, PTSD is linked to heightened sensitivity to
glucocorticoid signals, due to enhanced glucocorticoid receptor (GR) signaling (due to increased glucocorticoid
receptor expression and/or decreased expression of its inhibitory binding partner FKBP5). Both GR and
FKBP5 gene variants are linked to PTSD incidence or severity, indicating of a role as trait variable influencing
disease development or progression. PTSD-related GR and HPA axis dysfunction are emulated in rodent
models, suggesting that they contribute to pathological behaviors associated with trauma. Pathological
mechanisms are thought to be driven by disruption of prefrontal cortex-amygdala connections controlling
expression of fear, anxiety and emotional memory, processes that are in turn subject to regulation by stress
hormones. This proposal tests the hypothesis that post-trauma glucocorticoid signaling disrupts prefrontal
(infralimbic) cortex and amygdala circuitry responsible for fear regulation, causing lasting decrements in
neurocircuit function and behavior. Here we employ pharmacological, genetic and physiological approaches to
understand glucocorticoid control of neurocircuit mechanisms driving posttraumatic pathologies, using a well-
characterized and reproducible rodent single prolonged stress (SPS) model to emulate core symptoms of
PTSD. Aim 1 uses pharmacological approach to either block or amplify infralimbic cortex glucocorticoid signals
in the aftermath of SPS, testing the impact of altered glucocorticoid receptor binding on generation of
enhanced anxiety related behaviors, social withdrawal, impaired extinction of fear memories and impaired
decision making. Novel machine learning approaches are used to model the constellation of behavioral deficits
following SPS and determine how blocking or amplifying infralimbic GR signaling modifies the pathology
model. Aim 2 uses a recently-developed conditional rat GR deletion model to test the specific role of the
infralimbic GR signaling in mediating stress pathologies, including direct query of GR action across the
infralimbic-basolateral amygdala connection. Aim 3 addresses possible mechanisms of post-SPS GR signaling
in disruption of infralimbic-amygdala circuit function, employing electrophysiological approaches to test the role
of GR signaling in causing long-term pathological reductions in prefrontal excitability. Overall, these data are
expected to define the role GR binding in generation of neurocircuit pathology related to PTSD, providing a
springboard for evaluating the utility of new or existing GR modulating agents as a putative disease treatment
or prevention.

Public health relevance
Post-traumatic stress disorder is a major problem for the VA. According to the VA, 14% of individuals that served in OIF or OEF develop PTSD, a rate that is substantially higher than the general population (7-8%). Women veterans appear to be more a risk for PTSD than men. Frontline treatment options (e.g., SSRIs) can improve symptoms but do not currently offer a cure. To develop further strategies to this end, it is critical to understand the foundations of the disease process as it develops. This proposal examines the role prefrontal cortex stress hormone (glucocorticoid) receptors in driving development of PTSD behavioral pathologies, ranging from anxiety symptoms, exaggerated fear responses and cognitive dysfunction. These studies employ pharmacological, genetic and cell physiological approaches to test the role of abnormal glucocorticoid signaling in generation of behavioral disturbances in rodent models. Our results will inform future strategies to target abnormal stress hormone signals in behavioral pathologies.